The Ferret as a model for evaluation of antiviral efficacy against Venezuelan equine encephalitis virus

Project Summary
Venezuelan equine encephalitis virus (VEEV) is a mosquito-borne, New World Alphavirus that has caused several major
epizootic and epidemic disease outbreaks in humans and equines in Latin America. In addition to natural mosquito-borne
infection, the potential biothreat inherent in the ability to disseminate these viruses via the respiratory route has driven the
development of antiviral drugs for this route of exposure. We propose to assess the pathogenesis of the ferret model of
intranasal administration of VEEV INH in the ferret; VEEV INH is the proposed human reference challenge strain for
vaccine and therapeutic development in animal models. We will assess the model’s potential for preclinical testing of
antivirals using our lead antiviral, BDGR-354. We have extensively tested BDGR-354 in the mouse, which provided 100%
protection by oral administration of BDGR354, prophylactically and therapeutically; and oral is the route proposed herein
for administration of BDGR-354. Under the Animal Rule Regulatory pathway our PreIND submission for BDGR354, we
must propose two animal models to demonstrate efficacy. Other small animal models of VEEV include hamsters and cotton
rats, however, these models do not sufficiently recapitulate disease. An additional model is nonhuman primate (NHP),
however, given the expense and scarcity of NHP, a ferret model for the neurotropic alphaviruses will be of great benefit to
the antiviral community. Given that the ferret model is accepted by the FDA for safety and efficacy testing of influenza
virus vaccines and therapeutics, we expect that that FDA will be supportive of this animal model. Hence, we propose to
evaluate the virology and pathogenesis of the ferret model for VEEV-INH (aim 1), and we propose to use this model to
evaluate the toxicity, prophylactic and therapeutic efficacy of BDGR-354 (aim 2). The proposed studies of intranasal
infection of VEEV in ferret will provide new insights into the spatial and temporal dynamics of virus and pathogenesis. We
hope the studies proposed with BDGR-354 in VEEV-ferret will provide a novel approach for preclinical studies in support
of PreIND submissions for small molecules for the neurotrophic alphaviruses. Regardless of our success with BDGR-354,
the studies will inform approaches in the development of novel therapeutic strategies in the ferret for the prevention or
treatment of neurotropic alphavirus pathology.

Public health relevance
Project Narrative The encephalitic alphaviruses are important epidemic and biothreat agents, and there are currently no effective therapeutics. In addition to natural mosquito-borne infection, the potential biothreat inherent in the ability to disseminate these viruses via the respiratory route has driven the need for antiviral drugs for this route of exposure. The goal of the research proposed in this application is to advance understanding of respiratory infections in ferret in Venezuelan equine encephalitis virus to inform the development of future treatment strategies for neurotropic viruses for this route of exposure.